An Adaptive Intervention to Improve Health, Safety and Empowerment Outcomes Among Immigrant Women with Intimate Partner Violence Experiences

Intimate partner violence (IPV) disproportionately affects immigrant women. However, immigrant women
remain an understudied and underserved population in need for evidence-based rigorously evaluated culturally
competent interventions that address their health and safety needs. This study uses a sequential, multiple
assignment, randomized trial (SMART design) to rigorously evaluate an adaptive culturally informed
intervention tailored to needs of immigrant women with IPV experiences. For the first stage randomization, the
study will use data collected by the ongoing weWomen randomized controlled trial (RCT) (1R01HD081179-
01A1) in which abused immigrant women are being randomized to the WWmyPlan online intervention or the
usual care control arm and safety, mental health and empowerment outcomes are assessed at 3, 6 and 12
months following up. In this study, women who do not report significant improvement in safety (i.e., reduction in
IPV) and in empowerment from baseline to 12 months (i.e., non-responders) in the weWomen RCT will be re-
randomized to a second stage randomization with augmented intervention components (i.e., text messages
and phone calls). Data on outcomes (safety and empowerment) will be assessed at 6 and 12 months of re-
randomization. In Phase 1 (formative phase), using a concurrent mixed methods design, we will conduct in-
depth interviews with current weWomen participants on the utility of WWmyPlan online intervention
components (qualitative) and analyze moderators of intervention response in the safety and empowerment
outcomes at 12 months follow-up in the ongoing weWomen RCT (quantitative). Further, based on input from
experts on IPV among immigrant women and from diverse groups of immigrant survivors of IPV, we will
culturally tailor and pre-test the content of the augmented components (text messaging and phone calls)
(qualitative). In Phase 2 (Enhanced intervention evaluation) phase, by re-randomizing participants, we will
assess the relative effectiveness of two strategies for augmenting WWmyPlan (text only or a combination of
text and phone) on safety and empowerment outcomes among the non-responders of the WWmyPlan
intervention. In addition, the study will compare the non-responder group of women to the responder group of
WWmplan intervention to determine if the strategies of augmentation brought the non-responders to the level
of responders on safety and empowerment. In Phase 3 (Dissemination and Implementation), the study will
identify facilitators and barriers to the adoption, implementation and maintenance of use of the original and
augmented intervention by programs serving immigrant women and design strategies to decrease barriers and
build on strengths. For this, the study will collect data from providers serving immigrants and organizational
leaders as well as immigrant survivors of IPV who received WWmyPlan only and those who received the
augmented components. The intervention will result in an evidence-based culturally informed intervention for
immigrant survivors of IPV for use by practitioners serving immigrant women.

Public health relevance
Project Narrative Immigrant women are disproportionately affected by intimate partner violence experiences and its negative consequences. This study will provide empirical support for the utility of a culturally informed technology-based intervention for promoting abused immigrant women’s safety, empowerment and overall health and well-being.